SUPPORT SERVICES FOR THE CTEP PHARMACEUTICAL MANAGEMENT BRANCH (PMB)

The objective of the “Support Services for the Pharmaceutical Management Branch (PMB)” contract is to provide logistical and administrative support to Government staff within PMB and across multiple Programs within DCTD. The Contractor supports PMB functions by primarily providing support of IND agent management and distribution (e.g., order processing, transfers, local destruction, investigator brochure distribution, stock recovery notice distribution, etc.), person registration processing and maintenance, curation of a database [Enterprise Core Module (ECM)] containing an NCI list of organizations associated with NCI trials, as well as, helpdesks for managing the investigator, sub-investigator, associate, and organizations databases in compliance with IND regulations and DCTD policies.